SELEGILINE TRANSDERMAL SYS IN HIV COGNITIVE IMPAIRMENT

The primary goal of this study is to asses the tolerability and safety of the STS in HIV-seropostive individuals with established mild to moderate cognitive impairment. A secondary objective of this study is to explore the effects of STS on cognitive function.